Comparative Bioenergetics of Aging

Project Summary
The University of Alabama at Birmingham (UAB) proposes to renew a Nathan Shock Center of Excellence in
the Basic Biology of Aging focused on comparative bioenergetics and aging. Energetics is comprehensively
defined for this purpose as the study of the causes, mechanisms, and consequences of the acquisition,
storage, and utilization of metabolizable energy. Comparative energetics is the study of metabolic processes at
multiple scales and across multiple species, in this case as it relates to health and aging. Nearly a century of
aging research has reinforced the link between energetics and aging. In modern terms, this link is reified as
dysregulated mitochondrial function, metabolic signaling, and nutrient responsiveness. The twin objectives of
the Center will be to 1) explore in greater depth and detail than previously possible the complex relationship
among cellular and organismal energetics and their relationship to whole organisms' energetics, health, and
aging, and 2) provide quantitative, state-of-the-art technologies and novel methodologies in the assessment
and analysis of bioenergetics to the geroscience community at large. In pursuit of these objectives, we will
continue to provide three Research Cores. 1) The Comparative Organismal Energetics Core (a.k.a.
Organismal Core) will provide expertise and cutting-edge instruction and methodology for determining
complete whole-animal energy balance (intake, assimilation, and expenditure) and body composition, including
regional distribution of white and brown adipose tissue, in living animals of various species, including worms,
flies, fish, mice, or other mammals, under diverse temperature or activity regimes. 2) The Comparative
Mitochondrial Health Assessment Core (a.k.a. Mitometabolism Core) will provide integrated, quantitative
mitochondrial functional analysis at the level of the organelle, cell, or tissue for both traditional and emerging
animal models, including targeted metabolomics, assessment of mitophagy, and oxidative stress.
Mitochondrial-nuclear exchange models also will be available to enable experiments that evaluate the
contribution of mtDNA variation to bioenergetics. 3) The Comparative Data Analytics Core (a.k.a. Analytics
Core) will provide innovative analytic approaches to data sets linking comparative energetics to organismal
health and longevity.
With these Research Cores plus the Administrative Program Enrichment Core (Admin Core) and Research
Development Core (RDC), we aim to: 1) facilitate hypothesis-driven research and leverage these technologies
into new projects, interactions, and collaborations nationwide in basic aging research; 2) foster meaningful
novel interactions among investigators within UAB and across the region and country; and 3) provide
resources, education, training, and direction to junior investigators through the intellectual resources and
research infrastructure the Center will develop.

Public health relevance
Project Narrative The University of Alabama at Birmingham Nathan Shock Center of Excellence in the Basic Biology of Aging will continue to provide state-of-the-art research services as well as diverse cells and animals for researchers investigating the links between energetics, health span and the aging as well as provide education and training in bioenergetics theory and analysis from the level of the organelle to the cell, tissue, organ, and organism.